Social determinants, trauma, and mental distress among forcibly displaced populations in low- and middle-income countries

PROJECT SUMMARY
The goal of the proposed fellowship is to prepare the applicant, Lauren Yan, for a career in global mental
health research to inform programmatic and policy interventions in vulnerable communities, with a particular
focus on forcibly displaced populations living in low-resource settings. To this end, the applicant proposes to
investigate social determinants of mental health, trauma exposure, and mental distress among adult displaced
Syrians in Jordan. The applicant will carry out the proposed research while engaging in individualized
mentorship, didactic training, and professional development opportunities targeted towards the following
training objectives: 1) advancing skills in latent variable modeling methods; 2) developing expertise in complex
causal inference methods; 3) gaining experience in new regions and contexts of humanitarian concern; and 4)
engaging in professional development opportunities. These objectives will address gaps in Ms. Yan’s training
and will help propel her toward a productive independent research career.
The proposed research is highly relevant for public mental health. Social determinants of mental health—the
living conditions and non-medical factors that impact mental health and illness—are critical to the well-being of
over 100 million displaced people worldwide. This population faces exceptional challenges related to
conditions of daily life, which compound the mental health problems associated with high trauma exposure.
While social determinants are promising preventive targets for reducing the global burden of mental disorders,
existing studies find heterogenous effects with unclear implications for intervention. There is also a paucity of
longitudinal evidence from low-resource settings—where most forcibly displaced people reside. Consequently,
social determinants’ mechanisms of effect are poorly understood in such contexts. Given these gaps in
knowledge, research from displacement settings in low- and middle-income countries is needed to inform
intervention approaches that more comprehensively support the mental health of displaced populations.
To address these gaps, the proposed research will use data from the Syrian Refugee Life Study to: 1) identify
the latent factor structure of displaced Syrians’ social determinants of mental health; 2) estimate the main
causal effects of social determinants and trauma exposure on mental distress; and 3) evaluate whether social
determinants moderate the relationship between trauma exposure and mental distress. The proposed research
aligns with Goals 2 and 3 of NIMH’s Strategic Plan by providing contextually relevant evidence to understand
mental illness trajectories and enhance prevention strategies.

Public health relevance
PROJECT NARRATIVE Despite social determinants’ known impact on the mental health of vulnerable and trauma-affected populations, including forcibly displaced people, there is little evidence from low-resource settings on the mechanisms by which these determinants affect mental health. The proposed project will utilize data from one of the first representative longitudinal studies with refugees in any context to: 1) identify the latent factor structure of displaced Syrians’ social determinants of mental health, 2) examine the main causal effects of social determinants and trauma exposure on mental distress, and 3) evaluate whether social determinants moderate the relationship between trauma exposure and mental distress. Findings from this study will inform measurement and targeting strategies for preventive interventions, also offering a methodological approach that can improve understanding of social determinants’ structure and significance in diverse populations of concern.